Calcium Driven Fibroblast Dysregulation in Human Atrial Profibrotic Remodeling

PROJECT SUMMARY: Atrial fibrillation (AF) is the most common cardiac arrhythmia (affecting ~1-2% of the
general population), resulting in markedly reduced quality of life and increased mortality, due to a combination
of altered hemodynamics, progressive atrial and ventricular dysfunction, and embolic stroke. Limitations in
current therapy allow AF paroxysms to progress to persistent forms of AF, as a result of extensive atrial
structural and electrical changes that facilitate AF maintenance (“AF begets AF”). Myocardial remodeling,
particularly atrial fibrosis, is a prominent feature of AF and contributes importantly to the vulnerable substrate
promoting and stabilizing the arrhythmia. From a therapeutic perspective, the time course of fibrotic
development is likely to define a window early in disease in which anti-arrhythmic pharmacotherapy can
terminate AF and slow disease progression, before losing efficacy in grossly remodeled tissue. Therefore,
therapies targeting the structural maladaptation, particularly fibrosis, could constitute novel antiarrhythmic
strategies. Ca2+ dysregulation is broadly recognized as a critical element in AF pathophysiology, and Ca2+-
dependent processes, both in atrial myocytes and fibroblasts, are thought to play an important role in AF-
associated structural remodeling. However, while fibroblast Ca2+ homeostasis has been clearly linked to fibrotic
outcomes, the mechanisms by which Ca2+ contributes to atrial fibroblast proliferation, differentiation, and
transcription of extracellular proteins remain largely unknown, particularly in human fibroblasts and during AF.
The overarching goals of this proposal are to investigate the basic molecular and cellular mechanisms of
human atrial fibroblast calcium homeostasis and to study their derangements in AF promoting atrial fibrosis.
Our approach will involve direct measurements of the major ion channels and molecular regulators of cytosolic
Ca2+ in human atrial fibroblasts, which will then be combined in mathematical models defining mechanisms of
Ca2+ entry, intracellular release and removal, and downstream fibrotic signaling. Together, these objectives will
establish a multiscale mechanistic platform for understanding the precise role of Ca2+ in the human atrial
fibroblast phenotypes that underlie remodeling of atrial myocardium in AF. We contend that these quantitative
frameworks will provide new mechanistic insights into atrial fibrogenesis in AF, potentially serving as platforms
for identifying new therapeutic targets. Each aim includes rigorously generated and validated modeling
frameworks, informed by novel experiments in human atrial fibroblasts, and testing of specific hypotheses.
Models and data will be distributed freely and widely via software and database infrastructure supported by Dr.
Grandi's lab and scientific networking sites.

Public health relevance
PROJECT NARRATIVE: Atrial fibrillation (AF) is the most common cardiac arrhythmia. Atrial fibrosis is a prominent feature of the progressive atrial cardiomyopathy that promotes and maintains AF, thereby increasing the risk of stroke and worsening cardiac diseases. This project aims to improve our understanding of the molecular mechanisms underlying AF-promoting fibrotic remodeling in humans via integration in and validation with new state-of-the-art computer models, ultimately leading to the development of improved treatment options.